MOLECULAR BIOLOGY OF CHLOROPLAST RIBOSOMES

This project will test the hypothesis that regulation of expression of chloroplast ribosomal protein genes which are coded by Nicotiana tabacum chloroplast DNA occurs at the level of transcription and translation. We analyze rps12-rps7 transcript processing and fully characterize the trans-splicing event which takes place in the maturation of rps12 mRNA. We will also establish gene-gene product relationships for chloroplast DNA encoded ribosomal proteins by identifying the polypeptides which are synthesized in vitro from cloned genes and their functional mRNAs. We will assess the importance of transcriptional regulation of these genes by measuring mRNA levels in vivo and in vitro experiments, examine the stability of the mRNA for several chloroplast ribosomal proteins, assess the contribution of promoter sequences to transcriptional regulation, and probe for evidence of protein factors which might regulate transcription of these genes. Translational control mechanisms will be assessed by examining differences in mRNA levels and their rates of translation for intron-containing and intron lacking ribosomal protein genes. Whether translation of chloroplast ribosomal genes is regulated by a feedback inhibition by the ribosomal proteins themselves will be tested. Ribosome binding site efficiencies of several of these genes will be compared and the significance of the binding site sequences examined by site specific mutagenesis experiments followed by measurements of translational efficiencies in vitro. The function of the rps12 gene product will be examined and we will attempt to utilize this gene to develop a selectable marker for chloroplast transformation.